A New Perspective on Leptin in Health and Disease

Abstract
A New Perspective on Leptin in Health and Disease
Over the past four years, the Scherer and Elmquist laboratories have worked on putting the concept to use that
lowering peripheral leptin levels is beneficial for the metabolic well-being of the organism. The starting point
was the generation of mouse models with an inducible reduction of leptin levels in adult animals and the use of
monoclonal antibodies that neutralize leptin. In contrast to historical expectations, these interventions resulted
in weight loss and enhanced insulin sensitivity. We have further elaborated on this concept in additional
physiological and pathophysiological settings. We have shown that weight loss, including weight loss induced
by incretins or FGF21, is critically dependent on leptin reduction and can be further enhanced by neutralizing
additional leptin in the process. On the other hand, weight gain and insulin resistance induced by anti-
psychotics can be prevented by leptin neutralization.
All these observations indicate that leptin is not merely a passenger associated with obesity but serves as a
driver of the obese phenotype. Furthermore, it conceptualizes the physiological role of leptin as an “energy-
sufficiency” signal - it is primarily a drop in leptin levels that the system responds to, with further rises in leptin
above baseline merely leading to pathological responses. Using a series of new tools we have developed over
the past four years, we strive to expand these concepts further in this renewal application. We now propose to
investigate the relationship of insulin and beta-adrenergic signaling to leptin production and release from
adipocytes. This also entails further studies into the regulation of full-length, signaling-competent leptin
receptors in peripheral tissues. In this context, we plan to elaborate on the pathophysiological aspects of leptin
signaling in the periphery by examining its potential as a fibroinflammatory agent. Using a series of novel
models and methods, we will examine the process of leptin-driven adipocyte delipidation, a phenomenon that
is restricted to young animals. Leptin sensitivity of adipocytes is abruptly lost after 10 to 12 weeks of age.
Most importantly, we are bearing future translational interventions in mind and have established a leptin-
deficient ob/ob mouse line in which we can ectopically manipulate leptin levels in a pharmacological dose-
dependent manner. This will allow us to precisely determine the lower threshold of circulating insulin levels
below which adaptive energy-conserving mechanisms are triggered. This enables us to calibrate future clinical
interventions with respect to minimal and maximal reductions of leptin that are therapeutically effective.
While conceptually novel, the approaches used here that critically depend on making a ligand (leptin) more
rate limiting, thereby leading to improved receptor (LEPRb) signaling, are fully compatible with the historical
data in the field, particularly as it relates to central leptin action. At the same time, we emphasize the peripheral
actions of leptin with respect to the fibroinflammatory milieu that it creates in several tissues critical for
metabolic well-being, including the liver, kidney, and lung.

Public health relevance
Relevance Statement Leptin is unquestionably a major driver of systemic metabolic well-being. However, the use of recombinant leptin as a therapeutic agent is extremely limited. We have recently established that reducing leptin levels is an effective way of enhancing leptin sensitivity. Reducing leptin leads to weight reduction, insulin sensitization, and reduced fibroinflammation in the periphery. Determining how leptin release from the adipocyte is regulated and how leptin directly or indirectly affects peripheral organs with respect to inflammation and fibrosis promises to lead to a better understanding of leptin action. As such, our proposed studies are of immediate relevance for the clinical implementation of approaches aimed at reducing leptin levels, as well as for the basic understanding of leptin action.